P30 Wilmer Core Grant for Vision Research

PROJECT SUMMARY
The Wilmer Eye Institute is one of the world leaders in vision research. Our research programs range
from basic/fundamental studies on the mechanisms of eye development and vision, to studies of the
genetics and pathogenesis of eye disease, to translational studies, to clinical trials, to epidemiological
and international studies of the worldwide causes of vision loss and disability. Wilmer has been
fortunate to have been funded through an NEI Core Grant for Vision Research for over forty five
years, and this funding has provided the infrastructure and core support for a wide variety of these
studies. The support that the Core grant has provided has not only been a tremendous aid in
facilitating Wilmer's diverse research programs and encouraging numerous collaborative research
projects, but it has also helped in making possible the training of many future vision scientists. In this
competitive renewal application, we are seeking support to continue these essential infrastructure and
core activities. We are proposing both continuation of past services, but also modifying and updating
some cores so as to better adapt to changing research needs, technologies, and priorities. The
modules for which funding is requested are cores for Imaging and Microscopy, Biostatistics,
Bioinformatics, Animal Modeling, and Drug Delivery and Nanotechnology. We feel that this module
structure, together with a rigorous administration support structure, will best serve and facilitate the
diverse vision research and training activities at Wilmer and throughout Johns Hopkins.

Public health relevance
PROJECT NARRATIVE Our NEI Core Grant for Vision Research (P30) research plan is designed to support and facilitate the success and productivity of the many and diverse vision research programs at The Wilmer Eye Institute and throughout Johns Hopkins, and also to encourage collaborative, innovative, and multi- disciplinary research studies.